Development of monoclonal antibody-mediated interventions to combat malaria

This contract is to provide proof of concept studies for the development of a monoclonal antibody to combat P. falciparum malaria.